GLUCOCORTICOID RECEPTOR AND POST-RECEPTOR EVENTS IN MAJOR DEPRESSION

Patients with major depressive disorder have a generalized relative resistance to glucocorticoid action. This resistance is manifested in pituitary-adrenal function and in mononuclear leukocyte response to glucocorticoids.